TB-RICC 3.0

TB-RICC 3.0 is designed to support the Regional Prospective Observational Research
Tuberculosis (RePORT) Consortium to produce the highest quality observational and
interventional research on tuberculosis (TB), TB-HIV, and TB-COVID-19. To accomplish this
goal, TB-RICC 3.0 will: i) collaborate with RePORT Country-Network Data Centers and
Biorepositories to ensure that common data elements (CDE) of the Common Protocol and
Specimen Tracking are accessible through the Global Data Template; ii) organize and/or
strengthen select sites to participate in diagnostic studies and clinical trials; and iii) support the
RePORT Country-Networks to ensure further development of TB diagnostic laboratories, TB-
RICC 3.0 specialized laboratories, and biorepositories. Aims of TB-RICC 3.0 are: Coordinating
Center Structure and Function: develop a Leadership Group and Executive Committee; assure
effective communication internally and externally; establish a Data Hub to provide seamless data
management from collection to analysis; establish Scientific Working Groups; a Scientific Review
Committee and an Administrative Core; facilitate grant submissions to potential funders and
partners. Data Harmonization: Develop a data hub to collaborate with country-level data centers
to facilitate multiregional data workflow using the REDCap Harmonist platform and other tools;
Research: catalyze TB, TB/HIV and TB/COVID-19 research within and across RePORT Country
Networks, and with external partners; prioritize study of TB close contacts to evaluate biomarkers
predictive of progression to TB across three “omics” platforms and three continents; Capacity
Building: develop modular remote courses for capacity building in the components of TB research;
Mentor early-stage investigator (ESI) development. TB-RICC 3.0 will deliver high-impact
innovative research to advance TB Science and TB Control

Public health relevance
New tools are necessary for tuberculosis control. The Regional Prospective Observational Research on tuberculosis (RePORT) coordinating center (TB-RICC 3.0) will discover predictors of development of TB and poor treatment outcomes and show that they are applicable across three continents. TB-RICC 3.0 will further support development of a network of sites to study promising new diagnostics, vaccines and drugs.